Identifying correlates of risk for future tuberculosis disease progression in children (INTREPID)

PROJECT SUMMARY
Background: Seventy million children globally are estimated to be infected with Mycobacterium tuberculosis
(Mtb), the bacteria which causes tuberculosis (TB). Of these, 1 million develop TB disease each year with a
quarter of them dying. Young children and those living with HIV are at high risk of progressing from Mtb infection
to TB disease and of developing severe forms of TB. They therefore represent a key population to target with
TB preventive therapy (TPT). Providing TPT to all children exposed to TB, especially in settings with high TB
burden, results in substantial overtreatment, with associated costs and toxicity. Yet the current tests of Mtb
infection are inadequate to predict future progression to disease in children. Developing new tests that accurately
predict which TB-exposed children will progress to TB, is a critical priority and will allow for more targeted
approaches to TB prevention. The identification of Mtb biomarkers in children should also consider relevant other
factors, including age, and exposure to other common pathogens. Several common viruses have been shown
to influence the risk of developing TB and are likely to affect biomarker signatures, yet few studies have evaluated
the influence of viruses on childhood TB biomarkers. Finally, current tests of Mtb infection indicate immunological
sensitization to Mtb rather than viable bacilli. If it were possible to identify a biosignature associated with Mtb
death, this could provide an additional strategy for targeted TPT approaches in young children. Our group has
an extensive track record of translational clinical research into pediatric TB. Our team consists of world leaders
in the fields of clinical pediatrics, epidemiology, immunology, proteomics, transcriptomics, and bioinformatics.
Methods: We will use samples from our three rigorously conducted studies in children <5 years, a drug-resistant
TB preventive therapy trial, an observational household contact study, and a prospective diagnostic study, all
conducted in a setting with high burden of TB and HIV. We will carry out a cross-sectional analysis to explore
differences in biosignatures along the TB disease spectrum, nested case-control studies in longitudinal cohorts
to evaluate risks of progression to Mtb infection and TB disease, and studies to evaluate changes in signatures
on treatment for Mtb infection and early disease. We will use proteomic (SomaScan), transcriptomic (RNA-seq),
metabolomic (mass spectrometry) and antibody (Systems Serology) approaches, and use a training/test design,
to identify biomarker signatures. We will examine biosignatures in the context of clinical co-variates and viral
exposure (PepSeq and RNA-seq). Finally, we will integrate the different approaches to generate the most robust
biomarker combinations and provide the most granular insight into the biology of TB disease progression.
Impact: Identifying novel biomarkers of TB disease progression in young children, including those living with
HIV, would transform the global response to pediatric TB. For the first time, it would be possible to prevent TB
by identifying and effectively treating children at the highest risk of future disease. This would have a substantial
impact on overall morbidity and mortality.

Public health relevance
PROJECT NARRATIVE Young children and those living with HIV are at the highest risk of progressing from Mtb exposure to tuberculosis (TB) disease and of developing severe forms of TB. We will use stored samples from young children already recruited to longitudinal clinical TB studies in South Africa and use transcriptomics, proteomics, metabolomics, and antibody approaches to identify biomarkers associated with progression to TB disease and treatment response. We will integrate the different approaches, together with information on viral coinfection and clinical and epidemiological covariates, to identify the optimal signatures to allow targeted TB preventive therapy.